Pediatric Fungal Network's (PFN) STudy of Rare Invasive Fungal DisEases in Immunocompromised Pediatric Patients (STRIDE) Administrative Component

ADMINISTRATIVE CORE
The Administrative Core of the Pediatric Fungal Network STudy of Rare Invasive Fungal DisEases in
Immunocompromised Pediatric Patients (PFN-STRIDE) Rare Diseases Clinical Research Consortium will be
based at Children’s Hospital of Philadelphia (CHOP) and led by PFN-STRIDE RDCRC Project Director/Principal
Investigator Brian T. Fisher, DO, MSCE with support of his clinical research team. Dr. Fisher’s team at CHOP
brings extensive clinical research experience, including work on previous Pediatric Fungal Network studies that
will provide a foundation for the research projects within PFN-STRIDE. The Administrative Core’s overarching
role will be to support execution of each of the proposed clinical research projects, and to ensure that all project
and core teams work in concert toward the vision and goal of improving knowledge, advancing diagnostics, and
improving clinical outcomes related to invasive fungal diseases in immunocompromised pediatric patients. The
core’s central aims will be to initiate and manage subcontracts, funds allocation, data use agreements, and
regulatory and clinical documents for all RDCRC participating clinical and research sites; to integrate and
collaborate with the NIH’s Data Management and Coordinating Center (DMCC) cores to create and maintain
data collection instruments, perform data cleaning, and establish data sharing standards and procedures for
specimen collection, management and tracking; to facilitate monitor all proposed activities for the Career
Enhancement Core, the Pilot/Feasibility Governance Core, Patient Advocacy Groups, and the External Advisory
Committee; and integrate and collaborate with the NIH DMCC Engagement and Dissemination Cores to ensure
RDCRC activities and accomplishments are communicated to key stakeholder groups.
In addition to Dr. Fisher, the Administrative Core will consist of a clinical research coordinator responsible for
regulatory and study site coordination; a clinical research project manager responsible for tracking project
budgets and deliverables; and a data analyst and biostatistician team responsible for ensuring adherence to the
data management plan and providing oversight for analysis planning and execution.
The Administrative Core will be bolstered by the robust resources available within Children’s Hospital of
Philadelphia’s Research Institute. Members of the core will work closely with each other, with RDCRC project
and core leaders, and the members of the DMCC to ensure synergies within the components of the RDCRC and
with the NIH Rare Disease Clinical Research Network.